Planning grant for CMV suppression to reduce mortality in hospitalized, HIV-exposed children

ABSTRACT
Increasing evidence suggests the detection of cytomegalovirus (CMV) viremia during serious illness may
identify a subset of individuals at elevated risk for poor outcomes. Associations between CMV viremia and
mortality have been found in immunocompetent adults admitted to intensive care in the US and Europe, and in
children living with HIV (CLHIV) and HIV-exposed uninfected (HEU) children hospitalized in Kenya. A trial in
HIV-negative adults with severe sepsis found that randomization to ganciclovir prophylaxis reduced the risk of
CMV reactivation and decreased oxygen dependency, suggesting a potential causal link between CMV
replication and outcomes. Together these data suggest suppression of CMV viremia may improve outcomes in
severely ill patients, and our goal is to conduct a randomized controlled trial (RCT) in HIV-exposed (CLHIV and
HEU) children in Kenya, where CMV prevalence nears 100% and inpatient mortality rates for severely ill
children are ~30%. The proposed trial will enroll children aged <24 months, with CMV viremia >1000 IU/ml,
and will randomize children to receive either standard of care or antiviral therapy to suppress CMV viremia.
Primary endpoints will be 6-month all-cause mortality, risk of neutropenia, and the combined outcome of death
or continued hospitalization at 15 days. Clinical and blood biomarkers of lung and intestinal injury, and
pathological investigations will inform mechanisms of intervention efficacy.
This proposal brings together an international team of clinical and scientific experts to develop a randomized
trial which will determine whether suppression of CMV viremia using antiviral therapy is safe and reduces
mortality and other deleterious outcomes in highly vulnerable children. This Planning Period will optimally
prepare the team and sites to conduct the proposed RCT. In Aim 1 we will finalize the protocol and all study
instruments, including the statistical analysis and data management plans, data safety and monitoring plan
(DSMP), data safety and monitoring board (DSMB) and charter, development of recruitment and consent
materials, case report forms (CRFs), and a detailed grant proposal budget for the clinical trial. In Aim 2 we will
convene the study investigators, clinical and scientific advisors and key government and community
stakeholders, and to develop a roles and responsibilities plan for multisite trial coordination and results
dissemination. In Aim 3 we will finalize the Manual of Operations (MOP) and prepare the sites to implement
the clinical trial protocol. If the intervention is found to be safe and effective, the collaborative team is ideally
poised to work with Kenyan facilities and policymakers to develop further trials and/or scale the intervention.

Public health relevance
NARRATIVE Inpatient and post-discharge mortality rates for children living with HIV (CLHIV) and exposed-uninfected (HEU) children are unacceptably high in sub-Saharan Africa. Cytomegalovirus (CMV) viremia is associated with poorer inpatient and post-discharge outcome in CLHIV and HEU and may contribute to mortality in hospitalized African children. We are planning a randomized trial to determine whether CMV suppression with antivirals improves survival in hospitalized CLHIV and HEU. The proposed planning grant will develop the study clinical trial protocol, prepare the sites for trial implementation, and convene the key scientific, government and community stakeholders needed to ensure collaborative design, execution, and dissemination of the future trial.